Protective effects of metformin against cigarette smoke-induced lung pathologies via regulation of fatty acids metabolism

Abstract
We have previously shown that metformin, a biguanide commonly used for the treatment of type 2 diabetes, has
robust protective effects against cigarette smoke (CS)- induced lung pathologies including accelerated aging,
apoptosis, inflammation, and oxidative stress in mice and in individuals with emphysema-dominant COPD.
Alveolar epithelial cell injury contributes to structural damage in emphysema with alveolar type 2 epithelial (AT2)
cells crucial in promoting lung re-epithelization and maintenance of surfactant synthesis after such injuries. AT2
cells are the most metabolically active cells of the alveoli and use fatty acid oxidation (FAO, which occurs mainly
in mitochondria) as fuel. We here show that AT2 cells are the main target of metformin’s protective effects against
CS-induced lung damage, by reducing AT2 oxidative stress burden and improving AT2 FAO and mitochondrial
function. In this proposal, we will test the central hypothesis that metformin protects AT2 cells against CS-induced
dysfunction and emphysema by ameliorating dysfunctional AT2 cell mitochondrial metabolism and FAO. We will
also prove that, by improving FAO in AT2 cells, metformin rescues mitochondria from CS-induced dysfunction. To
test these hypotheses, we will pursue complementary Specific Aims. Aim #1 will test the hypothesis that
metformin improves AT2 function in a CS-induced emphysema model by partial binding of mitochondrial complex
1 (MTC) of the electron transport chain. Using CS-exposed mice lacking a functional MTC1 subunit, and +
metformin, we will analyze the effects of metformin on AT2 cell function by assessing mitochondrial function/stress,
and AT2 surfactant synthesis and regenerative functional capacity. In Aim #2, will test the hypothesis that
metformin improves AT2 function in a CS-induced emphysema model by restoring FAO improving lipid metabolism
and mitochondrial function in AT2 cells. Using CS-exposed mice lacking CPT1A, a key enzyme in FAO, and +
metformin, we will determine the protective effects of metformin on AT2 cell surfactant synthesis and regenerative
functional capacity by assessing lipid metabolism, FAO oxidation and mitochondrial function/stress. In Aim #3, we
will use fresh lung samples from individuals with COPD and controls recruited prospectively to confirm our
preclinical finding that metformin protects the lung against CS and COPD pathologies by ameliorating AT2 cell
FAO and mitochondrial impairment and thus AT2 cell function. Simultaneously, using fresh and frozen blood from
samples from the same patients and from well-characterized existing COPD patients’ cohorts, we will also
investigate the circulating lipidomic profile associated with the use of metformin as a marker of metformin efficacy
in a selected subset of COPD patients. The characterization of the effects of metformin on FAO in a preclinical
emphysema model, and in patients with emphysema will pave the way to new strategies targeting a selected
category of patients that could benefit from metformin treatment.

Public health relevance
PROJECT NARATIVE In this proposal, we will test the central hypothesis that metformin, a common drug used in type 2 diabetes, protects against cigarette smoke (CS)-induced COPD by restoring lipid homeostasis and rescuing fatty acid oxidation (FAO) in alveolar type 2 (AT2) cells. We will use complementary in vitro and in vivo approaches to dissect the mechanisms by which metformin protects AT2 cells from FAO and restores mitochondrial metabolism, which is blunted by CS exposure, and to characterize the lipidomic profile of AT2 cells and blood samples from patients with COPD who have been using metformin. Our studies could stimulate the potential application of metformin in trials aimed at limiting emphysema progression in a selected subset of patients characterized by a specific lipidomic profile that could be targeted by metformin use.